Support in adolescents' cross-gender friendships: Understanding girls' disadvantage

Project Summary
During adolescence, friends meet more of youths’ relationship needs, including needs for support. Importantly,
despite hundreds of studies focused on same-gender friends, relatively few studies have considered cross-
gender friendships. Learning more about cross-gender friendships in adolescence, however, is important as the
prevalence of cross-gender friendships increases during adolescence. Moreover, better understanding cross-
gender friendships is especially important for girls because girls seem to be at a disadvantage in cross-gender
friendships. Specifically, boys perceive cross-gender friendships to be more supportive than do girls.
The gap in the literature is that the’ specific behaviors in cross-gender friendships associated with positive
perceptions of the friendships are unknown. This gap will be addressed in the proposed research by observing
60 cross-gender friend dyads (120 adolescents). Given the importance of social support to friendship, cross-
gender friends’ interactions will be observed in a context in which the adolescents disclose a problem and friends
have the opportunity to provide support (or not). Friends’ responses to adolescents’ disclosures about personal
problems will be coded into response categories. Some of these are engaged and positive (e.g., sharing a related
experience) and some are disengaged and negative (e.g., minimizing the problem). In a large study of same-
gender friendships, we found that girls produced more engaged/positive responses than boys and that receiving
engaged/positive responses from friends was associated with positive perceptions of the friendship. Gender
differences were not found for disengaged/negative responses and disengaged/negative responses were not
related to adolescents’ perceptions of the friendship,
The following hypotheses will be tested in the proposed research. Findings are expected to replicate previous
research indicating that boys perceive their cross-gender friendships more positively than do girls. In addition,
girls are expected to produce more positive/engaged responses to cross-gender friends’ disclosures than boys
(no hypothesis is put forth regarding gender differences in disengaged/negative strategies). Receiving
engaged/positive responses from cross-gender friends also is hypothesized to be related to perceptions of the
friendships as supportive and close (no hypotheses are put forth for disengaged/negative responses).
Importantly, a line of research that identifies specific behaviors in cross-gender friendships that are associated
with positive perceptions of the friendship could have significant applied implications for programs aimed at
promoting positive cross-gender interactions. Finally, the proposed research is innovative both in the focus on
cross-gender friendships and the application of a very detailed and nuanced coding system.

Public health relevance
Project Narrative Relatively little is known about cross-gender friendships. In the proposed study, 60 pairs cross-gender friends will be observed in a context in which friends can offer support. Girls are expected to offer more support than boys, and support is expected to be related to positive perceptions of the friendships, so findings may be useful for promoting positive cross-gender interactions.